Novel 7SK non-coding RNA fusions in soft tissue sarcomas to tumorigenesis

PROJECT SUMMARY
Soft tissue sarcomas (STS) are rare tumors of mesenchymal origin that are often characterized by diagnostic
fusion oncoproteins corresponding with tumor subtype. We have recently observed that STS also harbor a
significant number of non-coding RNA (ncRNA) fusions, with RN7SK (7SK) fusions being the most prominent.
7SK ncRNA fusions predominantly involve other RNA polymerase III transcripts, occur at specific 7SK
breakpoints which reflect known characteristics of secondary structure, and are enriched in primary tumors
over cell lines. Furthermore, the presence of 7SK fusions is associated with a unique gene expression
signature, independent of tumor subtype. This gene signature involves altered expression of transcriptional
networks linked to transcriptional regulation, splicing, and translation, known functions of 7SK and its fusion
partners. Along with the predicted secondary structure of ncRNA fusions, this suggests the potential for
significant disruption of normal 7SK regulatory function in these tumors. Our overall hypothesis is that 7SK
ncRNA fusions represent a common mechanism by which normal transcription regulation is disrupted in soft
tissue sarcomas, contributing to disease pathogenesis. This R03 grant has been designed to allow us to gather
essential preliminary data to understand the biological function of these ncRNA in STS and query the
prevalence of these ncRNA fusions in other tumor types. Two specific aims are proposed:
• Specific Aim 1: To determine effects of 7SK fusions on gene expression and tumor growth
• Specific Aim 2: To characterize the prevalence of ncRNA fusions in STS and normal mesenchymal
cells and to extend these findings to other types of cancer and their normal counterparts
If successful, this study will lay a foundation for future work focused on understanding the biology of ncRNA
fusions in tumorigenesis.

Public health relevance
PROJECT NARRATIVE Soft tissue sarcomas (STS) are rare tumors of mesenchymal origin that are often characterized by diagnostic fusion oncoproteins corresponding with tumor subtype. We have recently shown that some STS also have high levels of ncRNA fusions, and that within these tumors, ncRNA fusions are linked to disruption of transcriptional networks associated with transcriptional regulation, splicing, and protein processing, known functions of WT 7SK and its fusion partners. This R03 proposal is designed to gather additional preliminary data to further understand the biology of these ncRNA fusions, their prevalence in both cancer and normal cells, and how they may be contributing to disease progression.